RFA-DP-21-001 Pregnancy Risk Assessment Monitoring System (PRAMS) Grant

PROJECT SUMMARY/ABSTRACT
Arkansas PRAMS
Component A
The Pregnancy Risk Assessment Monitoring System (PRAMS) survey is an on-going,
population-based surveillance system that collects state-specific information about mothers'
behaviors and experiences that occur before, during, and after pregnancy that might affect their
health or the health of their baby. The survey was developed to reduce infant mortality and to
promote infant and maternal health. PRAMS provides state-specific information that is not
available from the birth certificate or other sources.
The long-term goal or aim of the Arkansas Pregnancy Risk Assessment Monitoring
System (PRAMS) survey is to reduce infant mortality and morbidity by collecting and
disseminating data that can be used to promote infant and maternal health by influencing
maternal and child health programs, policies, and maternal behaviors during pregnancy and
early infancy.
The specific objectives of the Arkansas PRAMS program in meeting these goals will
be to do the following:
1) Collect population-based data of high scientific quality on topics related to pregnancy
and early infancy;
2) Promote the use and increase the visibility of PRAMS data to educate healthcare
personnel about maternal and child health problems and factors related to these problems, to
encourage translation of the data into programs or strategies to improve maternal and child
health, and to inform or implement policies to improve infant and maternal health;
3) Analyze and disseminate PRAMS data to inform the healthcare community about
behaviors and experiences that affect infant and maternal health; and
4) Provide technical assistance to organizations or persons interested in using PRAMS
data.
PRAMS is a mail/telephone survey. Each month, the Arkansas Department of Health
randomly identifies a sample of about 150 recent mothers from the Arkansas birth certificate
files. Mothers who do not respond to either of three mail surveys are contacted for a telephone
interview.
Reducing infant mortality is a top priority for the Arkansas Department of Health (ADH).
Data from the PRAMS survey can be used to meet or address the objectives set for the
maternal and child health priorities and reproductive health priorities developed by the ADH
Family Health Branch.

Public health relevance
PROJECT NARRATIVE Arkansas PRAMS Component A PRAMS survey data can be used to improve public health by improving the health of mothers and their infants. The data helps us to understand mothers' experiences and behaviors that affect their health and the health of their infants. The long-term goal of the Arkansas Pregnancy Risk Assessment Monitoring System (PRAMS) survey is to reduce infant mortality and morbidity. The specific objectives of the Arkansas PRAMS program in meeting these goals are the following: 1) Collect population-based data of high scientific quality on topics related to pregnancy and early infancy, 2) Promote the use and increase the visibility of the PRAMS data to encourage translation of the data into programs, policies, or strategies to improve maternal and child health, 3) Analyze and disseminate PRAMS data to inform the healthcare community about behaviors and experiences that affect infant and maternal health, and 4) Provide data and technical assistance to organizations or programs interested in using PRAMS data. Arkansas PRAMS has met these objectives by: 1) Providing non-CDC funding and in-kind personnel to carry out the day-to-day PRAMS operations, including funding to pay contractors for both the telephone surveys and mail survey data entry, 2) Improving mail operations to encourage mothers to complete the survey and increase response rates through various strategies such as increasing incentives, launching a media campaign, and adding a third mail out, 3) Developing and disseminating PRAMS reports (e.g., chart books, surveillance reports) to the health community, 4) Collaborating with internal (e.g., Maternal and Child Health Branch/Arkansas Department of Health) and external programs (e.g., Arkansas March of Dimes, University of Arkansas for Medical Sciences) to analyze the PRAMS data for programmatic purposes, and 5) Responding to data requests from and providing technical assistance to a variety of internal and external programs that have a mission related to maternal and child health.